Systematic analysis of Proteus mirabilis transcriptional regulators that drive uropathogenesis

ABSTRACT
Urinary Tract Infections (UTIs) are common infections that represent a significant burden on healthcare
systems worldwide. In 2006 alone, UTIs were the source of 11 million physician visits and cost the
United States over $3.5 billion. A significant portion of these infections are Catheter-Associated UTIs
(CAUTIs), accounting for up to 40% of hospital acquired infections globally. A major cause of CAUTIs
is Proteus mirabilis, an understudied Gram-negative member of the Enterobacterales order. This
organism is most noted for its ability to swarm on agar and form urinary stones in infected patients.
Previous studies have used a mouse model of UTI to identify factors that contribute to fitness and
virulence in the urinary tract. While these datasets strongly implicate transcriptional regulators, there is
much to learn about transcriptional networks in this species. Toward this end, I have developed the
framework to employ Transcriptional Regulator Induced Phenotype (TRIP) screening to identify
specific regulators that contribute to uropathogenesis. TRIP leverages a library of strains containing
inducible expression constructs that each encode a single regulator. Pools of these strains will be
inoculated into the mouse model of UTI to assess comparative fitness. Sequencing and bioinformatic
analyses will be used to assess relative fitness of TRIP strains and identify strains with a competitive
edge in the bladder environment. After identifying these key regulators, I aim to define the downstream
regulatory networks using RNA-sequencing and employ genetic approaches, biochemical assays, and
the murine model of UTI to ascertain the molecular mechanisms behind the fitness advantage. Using
a systematic bioinformatics approach, I have identified 232 putative transcriptional regulators in the
HI4320 genome. Only 3 of these regulators have defined regulons published in the literature. Thus far,
35/232 (15%) of the constructs have been generated. During library construction, I have validated the
TRIP framework using a variety of techniques (growth curves, qRT-PCR, and plasmid maintenance
experiments). These studies indicate that stable expression of regulators is not broadly toxic, the
selected promoter is inducible, and the construct vectors are stable both in vitro and in vivo. This project
represents the first in vivo application of TRIP and will identify regulators and characterize key
regulatory networks that drive Proteus mirabilis uropathogenesis.

Public health relevance
PROJECT NARRATIVE Globally, up to 40% of hospital-acquired infections are catheter-associated urinary tract infections (CAUTIs). Proteus mirabilis is a key causative agent of CAUTI due to its ability to generate bladder stones and build crystalline biofilms that block catheters. This study aims to identify and define key regulatory networks in P. mirabilis that drive infection in the urinary tract.